Establishing reactive astrocyte memory as a risk factor for aging-related neurodegenerative disease

Project Summary:
Aging is the primary diver of neurodegenerative disease (ND), yet the etiology often remains elusive. Intriguingly,
transient neuroinflammation (e.g. from acute infection) is a risk factor for developing ND decades later. This
phenomenon has remained largely unexplored at the cellular and molecular level. My K99/R00 study focuses
on the role of astrocytes in this process, a cell type that is often perceived as an inert neural support cell, however,
they are essential for nervous system development, function, and regeneration, and have many parallels with
innate immune cells. Research including my own reveals that astrocytes respond to neuroinflammation and
injury with context-dependent molecular and functional changes referred to as “astrocyte reactivity”. In addition,
we observed that astrocyte reactivity is mediated through substantial epigenetic changes, however, if these
alterations are persistent after insult resolution is unclear. Indeed, if, or how, astrocyte reactivity resolves; and
how transient astrocyte reactivity affects future insults remains unexplored. I propose a novel concept that:
transient neuroinflammation results in long-lasting reactive astrocyte memory (RAM) – characterized by durable
epigenetic changes, which allow for rapid gene alteration upon a subsequent insult. During aging, RAM can be
inappropriately activated and contribute to ND onset and pathology. In this way, the astrocyte's response would
mimic trained immunity described in the peripheral myeloid lineage where transient insults impart long-lasting
“inflammatory memories” encoded by epigenetic changes. This inflammatory memory lowers the threshold for
subsequent insults and enhances the cellular response. However, during aging, trained immunity can be
inappropriately activated and contribute to pathologies such as cardiovascular disease and cancer. The objective
of the current study is to establish the novel concept of RAM; determine the functional consequences of RAM in
Alzheimer's disease (AD); and dissect the molecular mechanisms underpinning RAM. In Aim1 I will use mouse
models of acute neuroinflammation and matched transcriptomic and epigenomic sequencing to define RAM with
molecular precision. In Aim 2 I will use a mouse model of AD to functionally test the contribution of RAM to AD
onset and progression. Finally, in Aim 3, I will determine the molecular mechanisms required for RAM formation,
maintenance and recall by using astrocyte-specific gene knockdown methodology. This research will pioneer
the concept and understanding of RAM and its role in ND. Data from this study can direct new therapeutics
aimed at attenuating the maladaptive effects of neuroinflammation to limit ND pathology. This a critical goal for
the future of medicine given the aging population and increasing global prominence of ND.

Public health relevance
Project Narrative Viral and bacterial infections result in transient neuroinflammation and are a common occurrence throughout life, yet how or why temporary inflammation increases the risk of developing neurodegenerative disease (ND) remains elusive. Similarly, despite the key role of astrocytes in neuron function and modulating the immune response, they are often overlooked in the study of ND. The proposed research will address these outstanding questions and provide fundamental insight into how transient astrocyte reactivity affects future insults and how this impacts on ND.